Developmental regulation of epithelial cell

ABSTRACT__________________________________________________________________________________
Epithelial tissues line the organs, blood vessels, and cavities of multicellular organisms to provide protection,
regulate chemical exchange, and secrete hormones for the underlying tissue. Epithelial cells transition among
cuboidal, columnar, and squamous morphologies to maintain normal cellular functions, and improper changes
may contribute to many diseases, including carotid artery disease, Huntington's disease, and tumor
malignancy. The Drosophila follicular epithelium, which covers the developing egg chambers, provides an
excellent model for understanding how developmental signals control epithelial changes. A subset of follicular
cells undergoes a dramatic flattening process, changing from cuboid to squamous. While studies have
revealed molecules that can modify cell shape and are especially important in flattening, the genetic control of
this dynamic and complex squamous cell (SC) process remains unclear. We found that the zinc-finger
transcription factor Broad (Br) in the follicular epithelium is required to transition posterior follicle cells from
cuboidal to columnar shape early in oogenesis. We also discovered that suppression of Br expression in mid-
oogenesis by the ecdysone and JAK/STAT signaling pathways regulates cuboidal-squamous shape changes.
This contrasts with ecdysone’s known ability to positively regulate Br expression in other tissues. We now
propose to examine the mechanisms by which Br expression is negatively regulated during Drosophila
oogenesis with the goal of understanding how Br-driven epithelial remodeling is controlled. We hypothesize
that the ecdysone and JAK/STAT pathways negatively act on a common downstream target Br to
regulate the timing and location of this dramatic morphological change. To test our hypothesis, we will
first investigate the roles of ecdysone and JAK/STAT signaling in Br-mediated SC stretching (Aim 1); then
investigate the downstream molecules involved in Br-mediated SC stretching (Aim 2). Our findings will provide
a comprehensive understanding of the molecular and morphological steps involved in SC morphogenesis,
shedding new light on the causes of epithelial diseases.

Public health relevance
NARRATIVE_____________________________________________________________________________ Epithelial cell shape changes are critical for maintaining normal cellular functions, and improper changes may contribute to many diseases, including carotid artery disease, Huntington's disease, and tumor malignancy. This research identified a core protein, Broad (Br), which is mediated by the Notch, ecdysone, and JAK/STAT pathways to regulate the timing and location of epithelial shape changes. The proposed project will achieve a comprehensive, mechanistic understanding of the process to enable potential new understanding of related diseases.